MUSC SCORE Leadership Administrative Core

ABSTRACT
The Leadership Administrative Core (LAC) is the backbone of the MUSC SCORE operations. As it has in previous funding periods, the LAC will continue to provide the organizational framework for addressing emergent issues, budgetary concerns and daily operations within the SCORE. It will also ensure the integration of the SCORE within MUSC and across the national consortium of SCOREs. The LAC will (1) provide fiscal and administrative management for all program components; (2) provide scientific and programmatic leadership; (3) manage the SCORE Pilot Project Program; (4) support campus-wide, regional, and national cross-SCORE collaborations; and (5) oversee the SCORE Evaluation Program. During the next funding period, the LAC will build on its previous successes to expand the MUSC SCORE’s functionality as a valuable regional and national resource on sex differences in substance use disorders and continue to focus on ensuring a capable workforce is trained in sex differences research.

Public health relevance
The Leadership Administrative Core (LAC) is the hub of the MUSC SCORE, serving as the central coordinating point for all SCORE activities. It influences each of the research projects and Center cores, and brings the various components together to form a cohesive, functioning unit. The LAC also oversees SCORE outreach, collaboration, and evaluation efforts.